Targeting AMP Synthesis to Overcome Resistance to BH3 Mimetics in Acute Myeloid Leukemia

Project Summary
Treatment outcomes for older patients (aged ≥60 years) with acute myeloid leukemia (AML) remain poor.
Recently, combining the BH3 mimetic/BCL2 inhibitor venetoclax (VEN) with hypomethylating agents (such as
azacytidine) has emerged as first-line therapy for the older AML population. Despite promising early responses,
resistance to VEN, which is characterized by decreased mitochondrial apoptotic priming, emerges over time.
Defining how this occurs on a molecular level is pivotal to designing effective BH3 mimetic-related combinatory
therapy. My laboratory has been active in defining mechanisms underlying anti-leukemia drug resistance. Herein,
using preliminary studies
based on a CRISPR/Cas9 screen
of BH3 mimetic-resistant AML patient-derived-
xenograft (PDX) models, we reveal remarkably enhanced sensitivity to mitochondrial apoptosis after inhibition
of ADSS2, a less-studied enzyme functioning in de-novo AMP biosynthesis. Mechanistically, we found that
ADSS2 deficiency-mediated sensitization to BH3 mimetics was associated with downregulated AMPK activity
and reduced mitochondrial adaptation, such as mitophagy. Notably, when combined with a BH3 mimetic drug,
targeting de-novo AMP synthesis using an in-house ADSS inhibitor ablated AML in drug resistant animal models.
Thus, we hypothesize that in drug-resistant AML, high AMP synthesis due to ADSS2 upregulation promotes
AMPK signaling and antagonizes BH3 mimetic-induced apoptosis, and that targeting ADSS enzyme in
combination with BH3 mimetics would eliminate AML. In Aim 1, using patient samples, we will correlate ADSS2
levels with BH3 mimetic-responsiveness in primary AML cells. We will also determine whether ADSS2
upregulation in VEN-resistant samples is due to clonal selection of pre-existing ADSS2-high cells under BH3
mimetic-pressure by integrating single-cell (sc) genotyping with scRNA-seq. In Aim 2, we will define how ADSS-
dependent AMPK activity promotes poor responsiveness of AML cells to BH3 mimetics. Specifically, using
mouse models, we will determine whether AMPK downregulation is required for ADSS targeting-induced
mitochondrial vulnerability. We will also assess whether AMPK mediated mitophagy when activated underlies
ADSS2 activity in AML. In Aim 3, we will determine whether pharmacological targeting of ADSS enzymes
combined with a BH3 mimetic eliminates AML and conduct lead optimization of our ADSS inhibitors. We are the
first to identify ADSS2 as a druggable target against cancer. If successful, this work would support combining a
ADSS inhibitor with VEN as therapy for AML, given that the current VEN regimen has only short response
duration.

Public health relevance
Project Narrative Use of BH3 mimetics, such as venetoclax (VEN), to target antiapoptotic BCL2 family proteins has been proven effective against acute myeloid leukemia (AML). However, emerging resistance to VEN treatment highlights a pressing need to understand underlying mechanisms in order to develop more durable BH3 mimetic-related combinatory therapies. Herein, we will determine whether blocking de-novo AMP synthesis by targeting adenylosuccinate synthetase 2 (ADSS2), a key component of that pathway, overcomes resistance to BH3 mimetics and assess whether combining an ADSS2 inhibitor with a BH3 mimetic drug eliminates AML cells in- vivo.